The role of a Clostridioides difficile P-type ATPase in ferrosome formation and its impact on cellular physiology and pathogenesis

SUMMARY
Clostridioides difficile is a Gram-positive, spore-forming anaerobic pathogen, and the leading cause of
nosocomial and antibiotic-associated intestinal infections. Susceptibility to C. difficile infection (CDI) often follows
antibiotic treatment and subsequent disruption of the resident intestinal microbiota, however the rise of infections
in healthy young adults suggests that additional bacterial and host factors make important contributions to CDI.
To colonize the gastrointestinal tract, C. difficile must compete with host metal sequestrating proteins that
withhold nutrient metals to restrict microbial growth in a process termed nutritional immunity. Iron is the most
well studied metal in the host-pathogen interface and is withheld by host iron-sequestering proteins such as
calprotectin and lactoferrin. However, it is unknown how calprotectin and lactoferrin affect metal availability in
the gastrointestinal tract and impact the outcome of CDI. It is also unclear how C. difficile adapts to metal
limitation mediated by these two proteins and circumvents nutritional immunity during CDI. Thus, we set out to
interrogate the iron homeostatic systems in C. difficile and examine their physiological function. Our preliminary
data demonstrate that C. difficile undergoes an intracellular iron biomineralization process and produces faceted
iron oxide granules (ferrosomes) to maintain iron balance during transient iron overload. We also discovered that
a P1B6-ATPase transporter (which we have named FezB), regulated by both iron and the ferric uptake regulator
Fur, is required for ferrosome formation. Additionally, ferrosomes isolated from C. difficile cells exhibit a highly
ordered crystalline lattice structure that is distinct from any known iron oxide minerals. In this application, we
hypothesize that (i) FezB transports iron into ferrosomes and interacts with other factors during ferrosome
formation, (ii) ferrosomes serve as an important iron storage strategy and alleviate iron overload and oxidative
stress, (iii) stored iron in ferrosomes is released through a specific mechanism to support growth under iron
limitation, (iv) ferrosomes are produced within the vertebrate host to combat host iron sequestration, and (v) this
ferrosome system is activated in the inflamed gut and required for bacterial colonization and survival during CDI.
Experiments described in this proposal will test these hypotheses, elucidate the underlying mechanism of FezB-
dependent ferrosome formation, define the structural features of the ferrosome, and determine its impact on
cellular physiology and C. difficile pathogenesis. Furthermore, the findings from this application will determine
the significance of host-mediated iron sequestration during CDI and create a framework for developing effective
antimicrobial therapeutics to combat this important infection.

Public health relevance
NARRATIVE: Our preliminary data have demonstrated that the Gram-positive anaerobic pathogen Clostridioides difficile undergoes an intracellular iron biomineralization process and produces faceted iron-rich granules (ferrosomes) to maintain iron balance during transient iron overload, however limited information is known about this biological process. The experiments proposed in this application will elucidate the underlying mechanism of ferrosome formation, determine its impact on cellular physiology, and dissect its contribution to C. difficile pathogenesis. The findings from this proposal will determine the significance of host-mediated iron sequestration during C. difficile infection and create a framework for developing effective antimicrobial therapeutics to combat this important infection.